Molecular genetics of neurodegenerative pathogenic and protective pathways: The SCA1 perspective

Project Summary
Spinocerebellar ataxia type 1 (SCA1) is one of nine fatal inherited neurodegenerative
diseases caused by expansion of an inframe CAG trinucleotide repeat. Each repeat tract
encodes a stretch of glutamine residues in the affected protein, in the case of SCA1 the
protein is ataxin-1 (ATXN1). Symptoms of SCA1 include loss of motor coordination and
balance, slurred speech, swallowing difficulty, spasticity, and some cognitive impairment.
A characteristic feature of SCA1 pathology is atrophy and eventual loss of Purkinje cells
from the cerebellar cortex. Like many neurodegenerative disorders, SCA1 is typically a
late onset disease suggesting that physiological changes due to aging contribute to the
onset of the disease. There is currently no effective treatment. Identifying signaling
pathways and cellular mediators of SCA1 pathogenesis in the cerebellum leading to
ataxia and in the brainstem that underlie lethality are critical in the search for
therapeutics and are the focus of the research outlined in this application for continued
support.

Public health relevance
Project Narrative A challenge facing understanding pathogenesis of SCA1, and neurodegenerative diseases in general, is elucidating the relative contribution of each molecular pathway altered has in pathogenesis in the different regions of the brain affected. We will - 1) Perform a molecular characterization of ATXN1[154Q] knockin induced pathogenesis downstream of nuclear entry in regions/cell types other than cerebellar Purkinje cells. 2) Use a recently developed floxed ATXN1[146Q] mouse model to determine the regional/tissue contributions to SCA1-ilke phenotypes. 3) Examine the extent to which manipulation of the Cholecystokinin - Cholecystokinin 1 Recptor pathway is a potential therapeutic target for treatment of SCA1, other SCAs that involve Purkinje neuron degeneration and perhaps neurons in other SCAs affected brain regions.